The Penn Roybal Center on Behavioral Economics and Health: Solving for Scale and Impact with Design Thinking, Digital Platforms, and Dynamic Adaptation

In partnership with large health care and commercial entities that serve as field sites for testing and scaling
interventions the goal of the proposed Penn Roybal Center is to accelerate the pace and increase the reach
and impact of scientific discovery on the application of behavioral economics to health behavior change at
scale. To achieve this goal, our proposal has three strategic foci: Design thinking, digital platforms, and
dynamic adaptation. Design thinking ensures user-centeredness of and customized engagement with
interventions, avoiding one-size-fits-none pitfalls. Digital platforms enable us to test promising interventions in
ways that can readily be translated to scaled application and to better leverage scarce intervention resources,
increasing the probability of scalability. Dynamic adaptation opens up possibilities to “learn as we go” during
intervention trials using information on engagement and intervention responsiveness to drive further resource
allocation decisions. This strategic focus complements several themes highlighted in the RFA: targeting
mechanisms of behavior change (MoBC) common to multiple health behaviors, utilizing behavioral economics
approaches to improve individual behavior, and leveraging technology to ensure fidelity and scalability.
Deploying these strategies, the Behavioral Intervention Development Core will nurture early-stage pilots
through the NIH Stage Model with a plan to advance to larger-scale (Stages III and IV) field studies conducted
with private and public sector implementation partners. We will work with our strong network of collaborating
organizations on implementation and dissemination (Stage V) of effective interventions. Our Administrative
Core will provide infrastructure to support research activities in behavioral economics and health at the
University of Pennsylvania and among affiliated faculty at other universities.
Specific Aims are to:
1.) Facilitate and support research across the NIH Stage model that advances the translation of behavioral
economic concepts to improved health and health behaviors for older adults (NIH Stages 0-V);
2.) Cultivate testing of mechanisms of behavior change and early-stage feasibility pilots (Stages 0-I);
3.) Support testing of promising Stage I ideas with potential to improve the health at scale in research and
community settings (Stages II-IV);
4.) Collaborate with external health care organizations to disseminate our findings and support the
implementation of effective interventions (NIH Stage V).

Public health relevance
The goal of our proposed Roybal Center is to speed up the pace and increase the impact of scientific discoveries about how to change health behaviors to prevent premature aging. To do this, we focus on three innovative strategies: design thinking to incorporate the experiences of older adults; online platforms that help us conduct large-scale studies easily; and dynamic adaptation, which allows us quickly learn how different interventions work for different populations. With these strategies, we will design and conduct studies ranging from small pilots to ensure our interventions can work up to larger-scale studies with companies and health care organizations that show how interventions do work in real-world settings.